Cytosolic DNA is the Link Between Genomic Instability and Cardiovascular Aging

Premature aging syndromes in laminopathies caused by mutations in the LMNA gene, encoding nuclear
envelope protein lamin A/C (LMNA), are the prototypic examples of genomic instability, which is a hallmark of
“normal” aging. Cardiovascular involvement is the cardinal phenotype and the major cause of mortality and
morbidity. The pathogenesis of laminopathies and “normal” aging share several common mechanisms. LMNA
regulates mitochondrial function, telomere length, nutrient sensing, stem cell regeneration, and autophagy, which
are the classic hallmarks of “normal aging”. LMNA expression is reduced in “normal” aging. A similar set of
nuclear defects are observed in “normal” aging and laminopathies. LMNA also regulates several epigenetic
regulators of aging, including sirtuins and histone deacetylases. Furthermore, LMNA is essential for genomic
instability and induction and repair of the double-stranded DNA breaks (DSBs) as well as the mechanical integrity
of the nuclear membrane. These mechanisms are also the core mechanisms of “normal” aging.
We have shown that the cytosolic DNA (CyDNA)-sensing proteins CGAS/STING1 are induced and their
downstream effectors TBK1, IRF3, and NFKB are activated, and the senescence-associated secretory
phenotype (SASP) is expressed in the human hearts and mouse models of laminopathies. We also have
identified and defined the LMNA-associated domains (LADs) in human cardiac myocytes (CMs) and have shown
that LADs are shifted in laminopathies and regulate CpG methylation and gene expression. Moreover, we have
identified 711 DSBs (q<0.05) in the nDNA in the LMNA-deficient as compared to the wild-type (WT) CMs by
END-Sequencing (END-Seq). DSBs show a preponderance toward the protein-coding genes, which is consistent
with the role of the LMNA in defining the boundaries of TADs and TOP2B processing. Furthermore, we have
shown that deletion of the Mb21l1 gene, encoding CGAS, attenuates the phenotype in a mouse model of cardiac
laminopathies. Therefore, we logic that studying premature aging in laminopathies would provide insights into
the mechanisms that are shared with “normal” aging. The large effect sizes of the LMNA mutations would provide
a better resolution in discerning the deranged hallmarks of aging than the “normal” aging, whereby numerous
determinants, each with a small effect size, interact stochastically to induce aging. Thus, we propose to identify
and characterize the genome-wide DSBs in CMs, cardiac fibroblasts (CFs), and endothelial cells (ECs) in
laminopathies and the old WT mice by END-Seq, the former because of the involvement of multiple cell types in
laminopathies and the latter to assess the extension of the findings in laminopathies to “normal” aging. Likewise,
we propose to identify and characterize the sources of the CyDNA in CMs, CFs, and ECs in laminopathies by
CGAS ChIP-Seq. Moreover, we propose to determine the effects of genetic blockade of the STING1 on selected
hallmarks of aging and cardiac phenotype in laminopathies. The findings are expected to provide insights into
the molecular basis of premature CV aging in laminopathies and likely the hallmarks of “normal” aging.

Public health relevance
PROJECT NARRATIVE Aging is associated with the breakdown of the DNA in the nucleus of the cells. The broken pieces of DNA are released into the cytoplasm of the cells, where it is sensed by a set of specific proteins that initiate a cascade of events that leads to inflammation and aging of cells, organs, and organisms. Our goals are to identify the sites of these DNA breaks in the heart cells, characterize features of the cytosolic DNA, and block the activated pathway to assess its effects on the biological process related to aging.